NCI, National Clinical Trials Network Lead Academic Participating Site (LAPS) UG1 (funded extension)

As reflected in this application, Mayo Clinic has a long tradition of clinical research and
has been a supporter and active participant in the National Clinical Trials Network
(NCTN). Support of the NCTN includes formation of one of the founding organizations
(North Central Cancer Treatment Group, now part of the Alliance for Clinical Trials in
Oncology), sustained leadership roles in the NCTN and in clinical trials, as well as
active supporters of clinical trials. Multiple Mayo Clinic staff continue in current
leadership roles within the NCTN or NCI sponsored activities related to the NCTN. Of
particular note, Dr Evanthia Galanis was recently appointed as Group Chair of the
Alliance for Clinical Trials in Oncology. Mayo Clinic remains committed to making NCTN
trials a prominent part of its portfolio of clinical trials for cancer patients or patients at-
risk for cancer. This commitment is reflected in the prioritization of NCTN trials over
many other trials, the level of accrual to NCTN trials, supplemental funding for NCTN
trial activity, further refinements to the activation and monitoring of progress of NCTN
trials to ensure their success, the continued leadership role of Mayo Clinic physicians in
the NCTN member organizations, and an on-going commitment of the Mayo Clinic
Comprehensive Cancer Center to support this activity. Mayo Clinic physicians and
researchers continue to have an active role in not only patient accrual to NCTN clinical
trials, but to leadership in developing and leading trials. Mayo Clinic researchers also
continue to be active in presenting the results of these trials at national and international
meetings and high-impact journals, as described within the current grant application.
Mayo Clinic researchers have continued to be active in performing subsequent analyses
of the collected data, and meaningful use of the biospecimens collected from the trials
to transform the science of cancer care. Mayo Clinic has also continued to focus on the
development of junior investigators in the NCTN to ensure the continued active support
of NCTN member organizations and the success of NCTN clinical research. Finally,
Mayo Clinic is committed to making clinical trials available to all patients, regardless of
their racial, ethnicity, or socioeconomic background.

Public health relevance
Mayo Clinic has a long tradition of clinical research and has been a supporter and active participant in the National Clinical Trials Network (NCTN). With over 1.3 million unique patients seen each year (of which over 120,000 are patients with cancer), Mayo Clinic is committed to making clinical trials available to all patients regardless of their racial, ethnicity, or socioeconomic background. A major factor in allowing this to occur is through Mayo Clinic’s commitment to making NCTN trials a prominent part of its portfolio of clinical trials for cancer patients or patients at-risk for cancer.